Opioid Use and Acute Suicide Risk: The Real-Time Influence of Trauma Context"

Project Summary/Abstract
The ongoing opioid epidemic is among the worst public health crises in United States history, with over 200
people dying daily from opioid overdose. Opioid use and suicide co-occur at an alarmingly high rate, and
despite large-scale efforts, this rate of co-occurrence continues to escalate. Moreover, the co-occurrence of
opioid use and suicide is associated with a wide array of deleterious outcomes, most notably pre-mature death.
Consistent with recent NIDA initiatives, co-occurring opioid use and suicide is receiving growing attention as an
increasingly urgent public health priority. However, empirical examinations in this area continue to lag behind,
with no studies explicating the real-time longitudinal associations between opioid use and acute suicide risk;
this information is needed to inform targeted intervention and policy. Furthermore, it remains unknown how an
individualized trauma context—notably, proximal posttraumatic stress symptoms (PTSS)—may serve as a
trigger for co-occurring opioid use and acute suicide risk. Understanding the momentary associations among
PTSS, opioid use, and acute suicide risk is necessary for targeted and timely interventions for co-occurring
opioid use and acute suicide risk. This study addresses a critical gap in knowledge by using an ecological
momentary assessment (EMA) approach among 60 trauma-exposed adults who currently use opioids and
report suicidal thoughts and behaviors (STBs). Specifically, this project will use a novel intensive longitudinal
design to examine the unique influence of trauma context on immediate (acute) risk for co-occurring opioid use
and suicide risk. This project is significant in that the knowledge to be gained via ecologically valid EMA will
specify proximal and context-dependent risk for co-occurring opioid use and suicidality to advance intervention
efforts among this vulnerable trauma-exposed population. It is innovative because it utilizes a cutting-edge
EMA methodology and advanced quantitative methods to delineate the context-dependent nature of the
momentary relations among PTSS, opioid use, and suicide risk, with a focus on personalized statistical models
(idiographic) that can inform individualized treatment. The goal of this F31 is to train the Applicant for
successful independent research using novel intensive longitudinal designs to examine the time-sensitive
associations among PTSS, opioid use, acute suicide risk, with the overarching aim of informing mechanistically
driven, real-time interventions. Thus, this project will provide the Applicant imperative training and experience
in repeated assessment research, sophisticated multi-level analyses, grantsmanship, dissemination of findings,
networking, mentoring, and ethics. The research environment at the University of Rhode Island, including office
space, technology, and grant support, along with excellent Sponsors and Consultants with expertise in relevant
content areas, provide the ideal setting and mentorship to successfully conduct the proposed project.

Public health relevance
Project Narrative The co-occurrence of opioid use and suicide is an urgent public health concern that has received growing national attention. The proposed project is the first to disentangle the proximal role of trauma context in subsequent co-occurring opioid use and acute suicide risk in the daily lives of community individuals. Findings will specify time-sensitive and context-dependent risk for co-occurring opioid use and acute suicide risk to inform targeted and trauma-informed prevention and intervention efforts.